Indigenous Health Institute Project

This project supports student development training and faculty development training through a summer institute hosted by the Schools of Public Health from Canada and Johns Hopkins University Bloomberg School of Public Health. The participants are all members of Indigenous tribes and communities and work with the special initiatives linked to the Native American Research Centers for Health.